Southern California Research Center for ALPD and Cirrhosis

RP2 – Nuclear PDH1 drives epigenetic TIC reprograming in alcohol-associated HCC
ABSTRACT
Hepatocellular carcinoma (HCC) is the third leading cause of malignancy-related mortality in the world.
Metabolic liver disease such as alcohol-associated liver disease (AALD), metabolic dysfunction associated
fatty liver disease (MAFLD) or a combination of both sometimes referred to both alcoholic and non-
alcoholic steatohepatitis (BASH), are becoming a major etiologic background of HCC. Therapeutic efficacy
for HCC is limited due largely to therapy-resistance and recurrence in which tumor-initiating stem-like cells
(TICs) are implicated via their self-renewal activity driven by the pluripotency factor NANOG. Proposed
research addresses a novel epigenetic regulation of NANOG mediated by mitochondrion (mito)-nucleus
crosstalk in TICs which we hypothesize as a potential therapeutic target. The mito pyruvate
dehydrogenase (PDH1) is recently shown to translocate to the nucleus to supply acetyl-CoA from pyruvate
to stimulate H3K27 acetylation (H3K27ac) in stem cells. We identified the RAB7 GTPase-activating protein
TBC1D15 as a novel oncoprotein responsible for p53 degradation and NOTCH activation. TBC1D15 is
now suggested to mobilize mitochondria (mito) by untethering mito-endosome interactions. Our
preliminary results reveal: 1) NOTCH Intracellular Domain (NICD), TBC1D15 and mito fission protein 1
(FIS1) form a tripartite complex at the mito outer membrane in TICs; 2) mito are closely associated with
nuclei in TICs and this spatial feature is diminished by TBC1D15 knockdown (KD) which disrupts the
tripartite interaction; 3) increased nuclear PDH1 in TICs is blunted by TBC1D15 KD; and 4) PDH1 KD or
inhibitor treatment reduces H3K27ac at the NANOG distal enhancer, NANOG expression and self-renewal
in TICs. These results collectively suggest a novel epigenetic mechanism of NANOG upregulation
mediated by PDH1 which is translocated to nuclei via a mito-nuclear proximity facilitated by the NICD-
TBC1D15-FIS1 interaction.
Hypothesis: Mito-nucleus transfer of PDH1 generates pyruvate-derived acetyl-CoA in nucleus and drives
sustained NANOG upregulation via H3K27ac of its enhancer. The NICD1-TBC1D15-FIS1 interaction
initiates this PDH1 nuclear translocation and is a plausible therapeutic target for alcohol-associated HCC.
Aim 1. To dissect molecular mechanisms of the mito-nucleus transfer of PDH1:
1.1. To test if NOTCH1-TBC1D15-FIS1 interaction facilitates perinuclear mito localization and PDH1
accessibility to the nucleus; 1.2: To test the proposed PDH1 transfer mechanism in human HCC organoids;
1-3: To perform in silico analysis to establish the 3-D structural basis for the NICD- TBC1D15-FIS1
interaction and to screen for small molecule inhibitors which target the interaction and characterize their
activities by fluorescence polarization and microscale thermophoresis assays.
Aim 2. To determine if nuclear PDH1 generates acetyl-CoA to increase H3K27ac at the NANOG enhancer
to promote NANOG expression, TIC self-renewal, and HCC development:
2.1. To test the ability of newly identified inhibitors for the NICD-TBC1D15-FIS1 interaction to suppress
nuclear PDH1 and acetyl-co A levels, H3K27ac at the NANOG enhancer, and its transcription in cultured
TICs. 2.2. To test the inhibitor modalities shown to be efficacious in vitro in PDX mice and humanized HCC
FRG mice.
In essence, the proposed research aims to establish a novel HCC therapeutic approach which specifically
targets NANOG epigenetic upregulation facilitated by PDH1 nuclear transfer.